The Rho GTPases Cdc42 and Rac1 in diabetic Nephropathy

DESCRIPTION (provided by applicant): Project Aims The Rho GTPases Cdc42 and Rac1 are intracellular signaling molecules best known for regulating the actin cytoskeleton. However, additional roles modulating cellular responses have also been described. Rac1 is important for the activation of NADPH oxidase in nonphagocytic cells and Cdc42 appears to inhibit the generation of reactive oxygen species (ROS) by NADPH oxidase through competitive inhibition. Numerous lines of evidence reveal NADPH oxidase as a major contributor to diabetes/glucose-induced ROS-mediated injury and recent publications indicate excessive NADPH-mediated ROS production in the podocyte results in podocyte apoptosis, depletion, and disease progression in diabetic nephropathy. Thus, investigating mechanisms that regulate NADPH oxidase activation in podocytes could unveil new molecular targets and improved therapies in diabetes-induced injury. This proposal includes preliminary data showing that Cdc42 expression is reduced in the glomeruli of diabetic humans and in two mouse models of diabetic nephropathy. Constructing a conserved glomerular transcriptional network using genome-wide gene expression profiling from humans and mice, we find Cdc42 to be one of the most important regulatory nodes. Furthermore, we have generated and characterized mice with conditional deletions of either Cdc42 or Rac1 in the podocyte. Findings in these mice underscore the importance of Rho GTPases in podocyte biology and glomerular health. We hypothesize that a loss of Rac1 in podocytes will reduce ROS generation and apoptosis in the podocyte and result in amelioration of murine diabetic nephropathy. In contrast, a loss of Cdc42 will exacerbate podocyte apoptosis and diabetic nephropathy. Specifically we will: (1) Investigate the role Cdc42 and Rac1 on ROS induction and apoptosis in human podocytes IN VITRO in a high glucose environment using RNAi technology, and (2) Investigate the role of the Rho GTPases Cdc42 and Rac1 in podocytes IN VIVO in a mouse model of diabetic nephropathy with podocyte specific inactivation of Cdc42 or Rac1. Our third (3) aim will be to use the Systems Biology expertise of the Kretzler laboratory to define the glomerular transcriptional networks in diabetic mice with podocyte specific inactivation of Cdc42 or Rac1, and compare to glomerular transcriptional networks in wild-type diabetic mice and humans. Diabetic nephropathy is the leading cause of end-stage renal disease in the United States and has a large impact on human suffering and a substantial economic burden. Providing a mechanistic understanding of the role of Cdc42 and Rac1 in diabetic nephropathy will reveal novel disease pathways and therapeutic targets.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Rho GTPase Rac1 is a required component of NADPH oxidase, and Cdc42 can competitively inhibit Rac1-mediated NADPH oxidase activation. We will investigate the role of Cdc42 and Rac1 in the mechanistic link of hyperglycemia, NADPH oxidase, oxidative injury, podocyte death, and the progression of diabetic nephropathy using in vitro, in vivo, and systems biology approaches. Diabetic nephropathy is the leading cause of end-stage renal disease in the United States, and providing a mechanistic understanding of the role of Cdc42 and Rac1 in diabetic nephropathy will reveal novel disease pathways and therapeutic targets. The Rho GTPase Rac1 is a required component of NADPH oxidase, and Cdc42 can competitively inhibit Rac1-mediated NADPH oxidase activation. We will investigate the role of Cdc42 and Rac1 in the mechanistic link of hyperglycemia, NADPH oxidase, oxidative injury, podocyte death, and the progression of diabetic nephropathy using in vitro, in vivo, and systems biology approaches. Diabetic nephropathy is the leading cause of end-stage renal disease in the United States, and providing a mechanistic understanding of the role of Cdc42 and Rac1 in diabetic nephropathy will reveal novel disease pathways and therapeutic targets. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Title: The Rho GTPases Cdc42 and Rac1 in Diabetic Nephropathy (DN) A. Specific Aims. In this proposal, we will explore the role of Cdc42 and Rac1 in NADPH oxidase-mediated ROS production and injury in the podocyte with exposure to high glucose/diabetes in vitro and in vivo. We will use a systems biology approach to define the transcriptional response to podocyte-specific Cdc42 and Rac1 loss in a mouse model of DN and search for parallel pathways in human DN (Figure 1). Regulation of the Rho GTPases Cdc42 and Rac1 appears to play a crucial role in hyperglycemia- mediated oxidative stress. The selective inhibition of Rac1 in endothelial cells in diabetic mice reduces NADPH oxidase enzyme activity and protects against vascular dysfunction1, but this has not been examined in the podocyte. NADPH oxidase is a major contributor to ROS-mediated injury in the hyperglycemic state2-4, and Rac1 is key for the activation of NADPH oxidase in nonphagocytic cells8. Cdc42, however, inhibits NADPH oxidase activation through competitive inhibition of Rac1 binding9. In the podocyte, excessive generation of ROS results in early apoptosis, depletion, and disease progression in mouse models of DN, and this is prevented by NADPH oxidase inhibition10. Transgenic production of the antioxidant metallothionein in the podocyte alone ameliorates DN in mice, underscoring the podocyte's pivotal role11. In addition, Cdc42 and Rac1 regulate the activity of transcription factors (NFkB, AP-1, Sp1, and NFAT) in DN in both ROS-dependent and independent ways12. Therefore Cdc42 and Rac1 may be key mediators of ROS- mediated podocyte injury and transcriptional regulation that leads to disease progression in DN. Our preliminary data demonstrate that Cdc42 is a conserved regulatory node in a shared human-murine glomerular transcriptional network. The differential phenotypes in our Cdc42 and Rac1 podocyte-specific knockout mice underscore the importance of these Rho GTPases in podocyte biology and glomerular health. Thus, investigating mechanisms that regulate NADPH oxidase activation and transcriptional pathways in podocytes, such as Rho GTPases, could unveil new molecular targets in DN. Guiding hypothesis for Aims 1 and 2: Reducing Rac1 expression will protect against podocyte apoptosis through inhibition of hyperglycemia-induced, NADPH oxidase- dependent, generation of ROS. In contrast, a reduction in Cdc42 will exacerbate podocyte apoptosis through loss of Cdc42-mediated competitive inhibition of Rac1. 1. Investigate the role of the Rho GTPases Cdc42 and Rac1 on NADPH oxidase activity, ROS induction, and apoptosis in podocytes in vitro in a high glucose environment. We will use immortalized human podocytes with 'knockdown' Cdc42 or Rac1 using RNAi technology to establish the role of Cdc42 and Rac1 in the mechanistic link of hyperglycemia, NADPH oxidase, ROS generation, and apoptosis. 2. Determine whether podocyte-specific reduction of Cdc42 potentiates DN or podocyte-specific inactivation of Rac1 prevents DN in a mouse model. Mice with a podocyte specific reduction (heterozygous loss, +/-) of Cdc42 or deletion (homozygous loss, -/-) of Rac1 will be made diabetic with streptozotocin. This aim will establish that modulation of Cdc42 and Rac1 expression potentiates or prevents DN and demonstrate if the mechanism is likely through ROS-mediated podocyte apoptosis. Guiding hypothesis for Aim 3: Genome-wide transcriptional profiling of diabetic mice with and without a podocyte-specific reduction in either Cdc42 or Rac1, and subsequent comparison to human DN, will allow the discovery of Cdc42 and Rac1 dependent pathways for the pathogenesis of DN. 3. Define the glomerular transcriptional networks in diabetic mice with podocyte specific inactivation of Cdc42 or Rac1, and compare to glomerular transcriptional networks in wild-type diabetic mice and humans. Using experimental groups from Aim 2, we will define glomerular transcriptional networks using transcriptional pathway mapping and promoter modeling tools and then generate shared glomerular transcriptional networks between diabetic Cdc42+/- and Rac1-/- mice and diabetic humans. This will allow unique insight into the Cdc42 and Rac1 dependent transcriptional pathways for DN in mouse and man. Cdc42 Rac1 NADPH Oxidase Aims 1 & 2: in vitro & in vivo ROS (O2-/H2O2) Transcriptio n Factors (NF-kB, AP-1, etc.) Aim 3: Systems biology Apoptosis and depletion Progression of Diabetic Nephropathy Figure 1: The podocyte in a hyperglycemic environment: oxidant injury and transcriptional pathways